Center for Implementation Science: Administrative Core

ADMINISTRATIVE CORE: SUMMARY
The overarching goal of the Administrative Core of the Center for Implementation Science is
to provide the context and conditions to develop the Center as an independent, sustainable, and
comprehensive resource for Implementation Science at Dartmouth, regionally in New
Hampshire, and nationally. The Administrative Core will be the central organizing entity of the
Center for Implementation Science. Members of the Administrative Core will ensure that the
overall goals of the COBRE program are met by creating an administrative infrastructure for
multi-disciplinary research in implementation science. The proposed Administrative Core of the
Center for Implementation Science, supported by Centers of Biomedical Research Excellence
(COBRE) mechanism, will support and advance research by junior faculty, building on
Dartmouth's recognized academic and research excellence and more than 20-year successful
track record of COBRE centers. The Administrative Core will oversee and facilitate Center
activities to create new infrastructure in implementation science to support junior faculty to
expand their research focus toward developing, implementing, and sustaining evidence-based
interventions in the field of implementation science, while also supporting implementation
science regionally and across the IDeA network of INBRE programs. The Administrative Core
will be guided by the following specific aims: Aim 1: The Administrative Core will manage all
aspects of the Center for Implementation Science; Aim 2: The Administrative Core will support
the development and transition of Research Project Leaders to independent research funding;
and Aim 3: The Administrative Core will oversee the formative and summative evaluation
strategies marked with specific timelines and milestones by contracting with an outside agency.
Impact: The proposed Center for Implementation Science will provide needed funding, new
scientific resources, and mentorship to advance junior faculty into independent research careers
focused on the study and application of implementation science. The Administrative Core will
oversee the initial research projects that will support the development of a self-sustaining,
multidisciplinary, research program in implementation science and provide a needed resource
for IDeA Centers for Biomedical Research Excellence nationally to foster national collaboration
and accelerate NIH funding independence.